Redox Biology and Medicine Training Program

Project Summary
This proposal seeks funding for an NRSA Institutional Predoctoral Training Grant from the Systems and
Integrative Biology Program of the National Institute for General Medical Sciences. This grant will support
predoctoral training in Redox Biology and Medicine (RBM) leading to a Ph.D. degree at Wake Forest University.
The RBM Training Program is a multi-disciplinary, multi-departmental program that has as its goal the training
of researchers working at the interface of biomedical sciences, biology, chemistry and physics to communicate
and work across disciplines to delve into the specialized chemistry of oxidation and reduction reactions
underlying the pathophysiology of many diseases. The 34 members of the RBM training faculty are diverse and
highly collaborative, and include faculty from Biochemistry, Cancer Biology, Biomedical Engineering, Internal
Medicine, Microbiology and Immunology, Chemistry, Biology, and Physics. Seven physician or veterinarian
scientists (with MD, MD/PhD or DVM/PhD degrees) are also among the training faculty, encouraging
translational science. Participating faculty represent a balance of career stages, including Assistant (10),
Associate (11) and full Professors (13). Major scientific themes of the RBM Training Program include the
overlapping areas of (i) oxidative modifications regulating metabolism and signal transduction pathways, (ii)
redox regulation of nucleic acid metabolism and cell cycle, (iii) reactive nitrogen species biochemistry and
biophysics relating to human health, and (iv) redox-linked mechanisms of disease initiation, progression and
treatment. The RBM training program has a flexible curriculum built around a common core of required courses
(Fundamentals of Redox Biology and Medicine, MCB 715; Omics Data: Generation, Analysis & Exploration,
CABI 740; and at least one technology-specific minicourse or workshop), electives, as well as the discipline-
specific courses to meet the requirements of the Ph.D. programs of the trainees. Students in the program are
trained in such areas as chemical biology, omics (proteomics, lipidomics, metabolomics), biomedical
engineering, enzymology, animal models of disease, mitochondrial biology and computational biology /
bioinformatics as fits best to the research area of the individual and their Individual Development Plan. The
training program takes advantage of the activities driven by the Center for Redox Biology and Medicine in
coordination with other basic research and clinical centers at the institution, including a well-developed system
of interdisciplinary seminars and retreats to promote interaction among members of the program. Students
participate in trainee-focused Chalk Talks which foster development in the cross-discipline communication skills
so critical to the multi-disciplinary research in this field. We also offer specific training in skills for a wide variety
of potential careers for our Ph.D. graduates, including careers in academia, biotechnology and pharmaceutical
industries, intellectual property, and science communication and policy. The guiding principles of Diversity,
Equity, and Inclusion as well as anti-racism activities are at the core of our program and present at all levels of
organization (students, mentors, Executive Committee, and activities).

Public health relevance
Narrative Redox biology and medicine, the theme of this predoctoral training program at Wake Forest University for which funding is requested, denotes the specialized chemistry of oxidation and reduction occurring in biological systems which orchestrates metabolism and signaling to elicit specific cellular responses. Redox mechanisms support well-being and are also involved in the development and progression of many diseases. The goal of this training program is to bring scientists from diverse backgrounds and diverse programs such as chemistry, physics and molecular medicine together to train in the performance of interdisciplinary redox research to improve human health.